IS Hub Renewal (Year 2)

Project Summary
Ending the HIV Epidemic (EHE): A Plan for America has prioritized the vital role of collaboration across
Department of Health and Human Services federal agencies as well as state and local jurisdictions in order to
achieve the ambitious goals of a 75% reduction of new HIV cases by 2025, and a 90% reduction by 2030.
Implementation Science, although squarely anchored to the research enterprise, is uniquely positioned to
achieve cross-agency coordination and collaboration due to the intrinsic focus on context, spanning community,
clinical, and public health environments. Leveraging extant National Institutes of Health (NIH) HIV research
resources afforded by the CFAR and AIDS Research Centers (ARC) programs, a multisite Implementation
Science Hub network was established in FY 2020, with a data coordinating center. The University of Alabama
at Birmingham (UAB) CFAR Implementation Science Hub is fully committed to building upon the foundation
established during the inaugural three years of funding as part of this synergistic, integrated HIV implementation
science community. This will be achieved via the provision of technical assistance, coaching, training, and
consultative services to assigned EHE supplement awardees as a Regional Consultation Hub (RCH) and
coordination and collaboration with the Coordination, Consultation and Data Management Center (CCDMC),
with added value via the engagement of scientists pursuing and conducting NIH funded, EHE aligned
implementation science grants at UAB and/or via national inter-CFAR networks (e.g., CFAR Network of
Integrated Clinical Systems (CNICS)). Our interdisciplinary UAB CFAR IS hub team is committed to accelerating
innovation in HIV community engagement, health equity, prevention, healthcare delivery, treatment, and care.
Beyond supporting investigators on scientific matters pertaining to IS research designs, frameworks, measures,
and evaluation, we have provided vital guidance with pragmatic issues pertaining to academic-public health
partnerships, collaboration and publications, community engaged science, and regulatory and compliance
considerations, paramount to the success of projects conducted with non-traditional clinical, community and
public health research partners. Proposed activities are well aligned with NIH HIV/AIDS Research Priorities,
most notably substantively supporting research in the cross-cutting areas of “health disparities, behavioral and
social sciences research, epidemiology, information dissemination, implementation sciences, and training,” and
will be achieved via five specific aims: Aim 1: Coaching is centered on developing a project development plan
with each supplement / project PI, Aim 2: Consultation systematically includes guidance on application of the
IS logic model and identification of appropriate outcome measures for each project utilizing the IS cross walk,
Aim 3: Dissemination includes guidance on scholarly products informed by the project development plan, Aim
4: Collaboration is achieved with CCDMC and the other RCHs via the cross-site evaluation working group,
multi-site training seminars and workshops, and by engaging with NIH R-series, and Aim 5 Conducting a cross-
Hub multisite pilot implementation research project.

Public health relevance
Project Narrative The University of Alabama at Birmingham (UAB) Center for AIDS Research (CFAR) Implementation Science hub will provide coaching and consultation support to scientists receiving NIH supplement grants aligned with the national Ending the HIV Epidemic (EHE) initiative that seeks to reduce new HIV infections by 75% by 2025, and 90% by 2030. Proposed activities are well aligned with NIH HIV/AIDS Research Priorities, most notably supporting research in the cross-cutting areas of “health disparities, behavioral and social sciences research, epidemiology, information dissemination, implementation sciences, and training,” and will be achieved via five specific aims centered on: 1. Coaching, 2. Consultation, 3. Dissemination, 4. Collaboration, and 5. Conducting a cross-hub IS pilot with other CFARs and AIDS Research Centers (ARCs) across the country.